Astrocyte activity in amygdala-related fear conditioned behaviors

PROJECT SUMMARY/ABSTRACT
The overall goal of this research is to better understand how astrocytes in the medial subnucleus of the
central amygdala (CeM) modulate conditioned fear behaviors. We recently found using brain slices that
exogenous activation of astrocytes in the CeM powerfully regulates synaptic transmission and decreases
CeM neuronal activity. However, critical gaps remain in identifying the role of CeM astrocytes in vivo,
their contribution during fear conditioned behaviors, and the neurochemical pathways that couple the
concerted activity of neuronal and astrocyte networks in the CeM. The goal of this proposal is therefore
to address these gaps in knowledge by performing measurements of astrocytic and neuronal activity in
the amygdala in freely, behaving mice using optical and genetic methods. In Aim1 we will record the
activity of astrocytes in the CeM during the acquisition, expression and extinction of cued fear
conditioned behaviors. They will provide the first physiological evidence that astrocytes are specifically
and differentially activated during specific phases of conditioned fear responses. In Aim 2 we will
determine whether CeM astrocytes have an endogenous role in modulating amygdala-driven responses.
It will also further test the role of astrocytic endocannabinoid signaling in these behaviors. In Aim 3 we
will determine the cellular and behavioral consequences upon exogenous activation of CeM astrocytes
using chemogenetic and optogenetic methods. In summary, the proposed studies will provide a much
more detailed picture on the role of astrocytes in the central amygdala and extend our recent ex vivo
amygdala slice studies. This knowledge will pave the way for new pharmacological strategies to treat
anxiety/fear disorders, by taking advantage of the uncommon profile of receptor expression of astrocytes
to regulate their activity. Therefore, our studies will contribute to generate a new strategy to treat
neurological diseases, such as anxiety, post-traumatic stress syndrome by targeting a relatively
understudied cell type in the amygdala.

Public health relevance
PROJECT NARRATIVE Accumulating evidence indicates that astrocytes, classically considered to serve passive support roles, play important functions in learning, memory, and information processing by actively modulating neuronal activity and synaptic function. The present proposal aims to define the functional role of astrocytes in amygdala-related behavioral tasks using in vivo and in ex vivo preparations. Defining the impact of astrocyte-neuron signaling on amygdala function may reveal novel mechanisms involved in brain disorders, such as Posttraumatic Stress Disorder (PTSD) and excessive anxiety.